Chicago Area Surveillance, Statistics, and Analysis Network for Diabetes, with Representative Ascertainment

PROJECT ABSTRACT
Diabetes is an increasingly common chronic disease in children and adolescents under age 18
years and in young adults age 18 to 44 years. Previous diabetes surveillance efforts have
included (among others) the “SEARCH for Diabetes in Youth Study” and the “Assessing the
Burden of Diabetes by Type in Children, Adolescents, and Young Adults” (DiCAYA) Network.
The population-based registry approach in SEARCH was considered to be relatively expensive
and labor intensive; the DiCAYA network was initiated because of the potential that EHR
databases hold to provide efficient processes for diabetes surveillance. DiCAYA advanced
diabetes surveillance and illustrated challenges when using EHR data from multiple networks
and subsites across the country. This CASSIDY component A proposal, in collaboration with the
Chicago Department of Public Health, will contribute data from the Chicago Area Patient-
Centered Outcomes Research Network (CAPriCORN). In collaboration with other data
contributors in the CASSIDY network, we will apply expert knowledge to develop and to apply
the best algorithms for identifying incident and prevalent diabetes (by type) and diabetes
complications, risk factors for complications, and medication use patterns. The CAPriCORN
network includes many healthcare systems and a large patient base in Chicagoland. During
2020, more than 3.1 million patients (of all ages) visited a CAPriCORN-affiliated healthcare
organization. This study is innovative because it will leverage multisite data from one of the
most diverse -- in its patient population and in its facility types -- clinical research networks in the
U.S. CAPriCORN includes not only the academic medical centers in Chicago but also Cook
County Health and the AllianceChicago network of Federally Qualified Health Centers. This
study will advance understanding of the differences in the burden of diabetes (by type) by
demographic traits, health insurance status, and geographic area. This project will be valuable
for both the Chicago Department of Public Health and CDC.

Public health relevance
PROJECT NARRATIVE The burden of type 1 and type 2 diabetes has been increasing considerably among young people in the U.S. This project in the Chicago Area Patient-Centered Outcomes Research Network (CAPriCORN) with collaboration from the Chicago Department of Public Health will build upon and will go beyond previous multisite work that uses electronic health records data. This project will build an efficient and cost-effective diabetes surveillance system that addresses not only incidence and prevalence but also diabetes complications (acute and chronic), risk factors for complications, and medication use patterns. As noted in the RFA, these estimates will be reported by diabetes type, demographic traits, health insurance status, and geographic area, to identify disparities in diabetes burden.